PI3K-gamma signaling as a therapeutic vulnerability of POU2F3+ small cell lung cancer

ABSTRACT
Small cell lung cancer (SCLC) is a highly lethal and aggressive neuroendocrine tumor of the lung that is marked
by early metastasis and resistance to therapies leading to a median survival of only ~12 months. Tumors typically
respond to first-line platinum-based chemotherapy but rapidly develop resistance. Furthermore, only a small
fraction of patients responds to recently-approved immunotherapies. SCLC comprises four molecular subtypes,
including the POU2F3+ SCLC (SCLC-P) subtype, which transcriptionally mimics a pulmonary tuft cell and is
associated with the worst overall survival. However, SCLC-P remains poorly understood and lacks targeted
therapies. Thus, new therapeutic targets for SCLC, especially for SCLC-P, are critically needed. My preliminary
data suggests that SCLC-P is dependent on PI3K signaling and through re-analysis of multiple mouse and
human datasets that tuft cells and tuft-like cancers, including SCLC-P, surprisingly express PIK3CG (PI3K
gamma isoform). PIK3CG expression was previously thought to be restricted to immune cells, primarily myeloid
cells. Due to this lineage-restricted expression, in early-phase clinical trials, PIK3CG inhibitor IPI-549 has shown
favorable tolerability and lacks the dose-restricting toxicities common to pan-PI3K inhibitors. Thus, we
hypothesize that PIK3CG may be a clinically relevant vulnerability of the highly aggressive SCLC-P subtype.
Preliminary data using both a small molecule inhibitor and a PROTAC demonstrate increased sensitivity to
PIK3CG inhibition in SCLC-P. In this proposal, I will use genetic and pharmacologic approaches to determine if
PIK3CG and its regulatory partner PIK3R5 are uniquely necessary for the SCLC-P subtype (Aim 1) and if
PIK3CG inhibition in combination with chemotherapy is an effective therapy for SCLC-P in vivo (Aim 2). These
data will reveal a potential new therapeutic target of SCLC-P that we expect to lead to a clinical trial on PIK3CG
inhibition in SCLC. Trials have shown efficacy for PIK3CG inhibition in augmenting immunotherapy through
targeting myeloid derived suppressor cells. Thus, PIK3CG inhibition may ultimately have the dual effect of
targeting SCLC-P and enhancing immunotherapy, a first-line therapy for SCLC. Additionally, as PIK3CG is
enriched across tuft cells and tuft-like cancers, we expect these findings to have implications for other cancers
that take on a tuft-like state including prostate neuroendocrine cancer and olfactory neuroblastoma. The
proposed research will provide unique training opportunities in cancer biology, targeted therapeutic development,
and in vivo preclinical drug studies, which align closely with my training plan and career goals. The proposed
research will occur over two additional years of training at Duke University School of Medicine in the laboratory
of Dr. Trudy Oliver, followed by one additional year of clinical training.

Public health relevance
PROJECT NARRATIVE The tuft-like POU2F3+ subtype of small cell lung cancer (SCLC) is associated with the worst outcomes of the SCLC subtypes in response to chemotherapy and immunotherapy. The identification of PI3K-gamma signaling as a dependency of tuft-like cancers will significantly advance our understanding of this aggressive, yet poorly understood cancer type. As PIK3CG inhibition has shown a favorable toxicity profile in clinical trials due to its lineage-restriction, this work will potentially identify a new clinically relevant target for POU2F3+ SCLC and other cancers that adopt tuft-like states including prostate neuroendocrine cancer and olfactory neuroblastoma.